ALTERATIONS IN INSULIN'S ACTION WITH FASTING/REFEEDING

Rapid alterations in glucose transport and metabolism have been shown in rat adipose cells after fasting and refeeding. The mechanism for this was examined in rats fasted for 48 h and sacrificed plus/minus 6 d of refeeding. The results suggest that insulin resistance at the glucose transport level induced by fasting is due to a depletion of intracellular glucose transporters. In contrast, the hyper-responsive insulin-stimulated glucose transport activity associated with refeeding is not totally accounted for by a change in the number of glucose transporters and may also involve modulation of glucose transporter intrinsic activity.